Patient-Centered Diabetes Education as an integral part of an Electronic Clinic Note using the SEE-Diabetes Modules

Project Summary/Abstract
Diabetes self-management education and support (DSMES) is a central component of diabetes
management. For people with diabetes to fully achieve the clinical and health benefits of DSMES,
patients and providers must make decisions about DSMES together.
This project proposes SEE-Diabetes (Support-Engage-Empower-Diabetes), an educational decision
aid that will enable older people with diabetes in consultation with their providers to choose a DSMES
strategy with maximal potential to achieve clinical and health benefits. SEE-Diabetes will allow a tailored
presentation of patient-centered self-care information in the clinic note. This project will involve iterative
feasibility evaluation of SEE-Diabetes.
Aim 1 Determine SEE-Diabetes information needs of patients and providers
Aim 1 will identify and understand the information needs of patients and providers from primary care
and diabetes specialty care. This process will determine if (1) the clinic note would address DSMES
components relevant, irrelevant, and missing, (2) there are differences in information needs when they
are reviewing a clinic note.
Aim 2 Develop and refine SEE-Diabetes module for clinic note
Aim 2 will iteratively develop SEE-Diabetes modules to incorporate into EHR clinic notes and facilitate
personalized care. Three patient focus groups and three provider focus groups will iteratively evaluate
content validity, readability, and usability of SEE-Diabetes modules between focus groups.
Aim 3 Evaluate feasibility of SEE-Diabetes
Aim 3 will evaluate preliminary effect of SEE-Diabetes on patient and provider, their responses to the
SEE-Diabetes, and viability of study protocols such as recruitment and methodological issues.
Observation of clinical encounters via audio recordings will result in feasibility findings to address
barriers to implementation.
At the end of this grant, the project will have data showing the impact of the proposed SEE-Diabetes
on short-term outcomes of DSMES related to patient involvement and implementation barriers.

Public health relevance
Project Narrative Because of the high prevalence of diabetes mellitus, older Americans could benefit substantially from diabetes educational decision aid. The proposed educational aid will guide the health care team in effective patient-centered collaboration and goal setting without clinical disruptions to achieve health- related outcomes and improved quality of life. This research will contribute to knowledge that empowers older patients as active team players by increasing self-efficacy and by providing a tool to engage in practical application of self-care management.